AMIODARONE IN PATIENTS WITH POTENTIALLY LETHAL VENTRICULAR ARRHYTHMIA

To assess the safety and efficacy of very low doses of Amiodarone in the suppression of nonsustained ventricular tachycardia in patients with left ventricular dysfunction.